Impaired Sleep as a Target for Intervention Following Acute Organophosphate Intoxication

Organophosphate cholinesterase inhibitors (OPs) were developed as agricultural insecticides and adapted to
function as chemical weapons. OPs inhibit the acetylcholinesterase enzyme and acute intoxication can lead to
a cholinergic crisis, status epilepticus (SE) and, for individuals who survive, the development of spontaneous
recurrent seizures (SRS) and cognitive deficits. The current CounterACT PAR-24-030, supports research related
to the 1) evaluation of the natural history to 2) elucidate mechanisms related to long-term effects of acute-
intoxication, and in particular the development of SRS and cognitive dysfunction, that will 3) identify relevant
biomarkers to predict long-term outcomes and 4) identify new targets for therapeutic intervention. To date, little
is known regarding the acute- or long-term effects of acute-OP intoxication on sleep architecture. In the field of
epilepsy in general, the link between seizures and sleep disruption is complex, but well documented. Epilepsy
and vigilance stages show a bi-directional relationship, with epilepsy disrupting sleep, and sleep disruption
promoting seizures. Vigilance stages and seizures are each characterized by signature cortical electrical activity.
Moreover, it is suggested that sleep-wake deficits are, in part, responsible for cognitive deficits observed in
patients with epilepsy disorders. In fact, sleep enhancement is being pursued as an interventional strategy to
reduce the burden of the epileptic syndrome. We hypothesize that sleep disruptions in the days-to-months
following acute intoxication with the OP diisopropylfluourophosphate (DFP) play a key role in the development
and maintenance of lasting pathophysiology including sleep disorders, seizures and cognitive dysfunction. We
further hypothesize that restoring a normal sleep-wake cycle will be protective, preventing the development of
the worst outcomes when provided acutely, and, in the absence of early intervention, counteracting symptoms
when delivered chronically. In testing our hypotheses, we will necessarily assess each of the four topic areas
related to the CounterACT RFA as described above. Specifically, we will determine whether acute intoxication
with DFP leads to dynamic changes in sleep architecture in the days-to-months post-intoxication (natural history;
goal 1) and predict that the animals with greater sleep disturbance experiencing prolonged cognitive and seizure
disorders (sleep as a mechanism; goal 2). We further hypothesize that changes in sleep-wake phenotypes
observed in the initial hours-to-days following acute intoxication will predict the extent of cognitive and seizure
outcomes (sleep as a biomarker; goal 3). Finally, we propose that early intervention with the FDA-approved dual-
orexin receptor antagonist (DORA) Lemborexant will improve sleep phenotypes and protect against the
development of the worst seizure and cognitive disorders while delayed intervention will reduce seizure
frequency and duration and improve cognitive outcomes (sleep as a new target for intervention; goal 4). This
collaborative proposal, therefore, fills a critical unmet need in the field of countermeasures research, while
evaluating a potential therapeutic target and FDA-approved candidate therapy.

Public health relevance
In both rodent models and in humans, acute intoxication with organophosphates leads to an immediate cholinergic storm, resulting in acute status epilepticus, ecotoxicity and neuroinflammation with the potential for the development of spontaneous recurring seizures and cognitive dysfunction. There is evidence in both rodent models and in humans with epilepsy, that there is a strong relationship between sleep and seizure disorders, with altered sleep linked to both the presence of seizures and playing a key role in epilepsy-related cognitive impairment. We propose to rigorously evaluate the roll of sleep in the context of acute organophosphate intoxication and hypothesize that not only does sleep play a key role in the development and maintenance of seizures and cognitive dysfunction but also represents a novel target for intervention with FDA-approved dual orexin receptor antagonists to not only improve sleep, but reduce seizures and improve cognitive outcomes.